IMPROVING CHARACTERIZATION OF STROKE-RELATED WHITE MATTER DAMAGE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Comparing models of diffusion and their impact on tractography metrics in stroke damaged white matter tracts (initially corticospinal tract).